Novel subdivisions of the dorsal cortex of the inferior colliculus

The inferior colliculus is a major integration site in the central auditory system. Rate tuning for certain
behaviorally-important sound features, such as amplitude modulation, is first elaborated upon in the
inferior colliculus, suggesting that it plays an essential role in complex sound processing. Dysfunctional
inferior colliculus organization has been seen in a number of disorders of auditory processing, including
tinnitus, dyslexia and schizophrenia. Unfortunately, our understanding of IC circuitry, particularly amongst
its subdivisions, remains limited. We recently found an unexpected degree of functional heterogeneity in
a substructure within the inferior colliculus known as the dorsal cortex (DC). Previous work has suggested
that the DC does not have subdivisions or a tonotopic arrangement. However, using two-photon imaging
of the DC which allows dense sampling of its surface, our group and others have found two mirror-image
tonotopic maps on the DC surface. These maps divide the DC into a lateral portion (DCL) and a medial
portion (DCM). We have further found that the DCL shows strong preferences for amplitude-modulated
white noise, whereas the DCM shows preferences for pure tone unmodulated sounds. These data suggest
that there may be at least two functionally distinct nuclei within the DC. Here, we will further characterize
these functional differences between DCM and DCL and will determine if there are differences in response
properties to complex sounds, and will determine if DCM and DCL show differential plastic responses to
noise exposure. Successful completion of this work has the potential to add clarity to our currently murky
understanding of the role of the DC in auditory processing and potentially to define new brain subregions
in this structure. More broadly, given the importance of the inferior colliculus in auditory processing, this
work will provide additional insights into the general organization architecture of the inferior colliculus
which will facilitate a greater understanding and targeted therapies for its disorders.

Public health relevance
The proposed work will provide a greater understanding about the inferior colliculus, which is a brain region that is critical for sound processing. We will determine if a new way of subdividing this region helps to understand its role in processing complex sounds and in compensating for damage to the inner ear.